TSUKAMOTO (JOHNS HOPKINS UNIVERSITY) MCSP - LEAD OPTIMIZATION CHEMISTRY

This study is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to understand the basis of pain and enhance clinical pain management.

The National Institute on Neurological Disorders and Stroke (NINDS) and the NIH Blueprint
Neurotherapeutics Network (BPN) http://neuroscienceblueprint.nih.gov/bpdrugs/index.htm have a need
for the Medicinal Chemistry Support Program (MCSP) to provide a full-service facility and staff who would
support a medicinal chemistry discovery program beginning at the Lead Optimization Chemistry phase to
develop structure activity relationship (SAR) analysis and design, synthesis, in vitro absorption,
distribution, metabolism, excretion and toxicology (ADMET), computational chemistry/Computer Aided
Drug Discovery (CADD) and compound logistics of storage and shipping to support the Contributor
Tsukamoto (John Hopkins University) to develop a novel therapeutic effective in pain. This will be
achieved by advancing the SAR/SPR of their small molecule heterocyclic starting compound utilizing their
assays and in vitro ADMET to identify novel, selective inhibitors of the target enzyme that are directed at
pain. Our drug discovery approach will be to synthesize novel ligands based on the heterocyclic scaffold
that are potent inhibitors. Candidate molecules will undergo profiling to assess criteria specifically related
to the physicochemical properties of compounds in a therapeutic setting, including enzyme selectivity and
tests to determine potential interactions with key metabolic enzyme systems. The goal is to advance the
project to go/no go decisions on identification of a preclinical candidate). The data generated from this
contract will be used by NINDS, contributors or sponsored investigators in support of Investigational New
Drug (IND) application directed preclinical activities. The results of the efforts of this contract will be the
basis to advance preclinical candidate compounds for further development i.e., advanced PK and
toxicological evaluation in preparation of IND filings

Public health relevance
This study is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to understand the basis of pain and enhance clinical pain management.